Y-SPAN: Yale Translational Cerebroprotection Program in SPAN

Project Summary.
The project proposes a rodent preclinical stroke therapeutics testing site at Yale for the NINDS program
Stroke Preclinical Assessment Network (SPAN) to Support Translational Studies for Acute Cerebroprotection.
A team of investigators including basic scientists studying mechanisms of injury after stroke, translational
researchers, biomedical imaging specialists, and clinical trialists form a highly collaborative and interactive
team dedicated to testing candidate cerebroprotectants selected by NINDS under the oversight of a national
coordinating center. The overall goal is to identify the most promising candidates for novel stroke therapies
to then be tested in clinical trials, advancing the care for stroke patients.
In Aim 1 of the project we will establish the SPAN standard operating protocols and timeline for testing of the
interventions. In Aim 2, we will test the efficacy of candidate cerebroprotectants in multiple rodent models of
transient middle cerebral artery occlusion, including models incorporating aging and comorbidities. In an
exploratory Aim 3, we will test innovative methods to improve the predictive value of the SPAN testing
protocols to identify candidate treatments that will be efficacious in patients and enhance the impact of SPAN.

Public health relevance
Project Narrative. The project establishes a team of researchers dedicated to work together in a national network to determine the most promising new stroke therapies to then be tested in clinical trials, advancing the care for stroke patients. They commit to rigorous testing of potential treatments selected by NINDS to hold great promise for the treatment of stroke.